Mechanisms of marrow microenvironmental aging and their impact of progression of clonal hematopoiesis

Project Abstract
Mutated clones in hematopoietic cells, also known as clonal hematopoiesis (CH) are present in healthy
individuals and expand with aging. In spite of normal hematopoietic parameters, individuals with CH have
increased risk of myeloid neoplasms, cardiovascular risk and all-cause mortality. We recently showed that the
aged microenvironment contributes to hematopoietic stem cell fate choices. While the presence of clonal
hematopoiesis in healthy individuals has been widely reported, and its expansion with aging is established,
whether the aging microenvironment modifies clonal dynamics and contributes to clonal selection leading to
progression to myelodysplastic syndromes (MDS) remains unexplored. Sirtuin6/SIRT6 is a regulator of genome
and epigenome stability. SIRT6 is responsible for more efficient DNA repair in long-lived species. Moreover
SIRT6 plays a critical role in suppressing retrotransposon expression, demonstrating that retrotransposon activity
directly contributes to the progeroid phenotype in mice lacking SIRT6, in part through activation of innate
immunity. Nucleotide reverse transcriptase inhibitors (NRTIs) developed as HIV drugs, inhibit retrotransposition,
reduce inflammation, improve aging biomarkers in wild type mice, and extend the lifespan of progeroid mice
lacking SIRT6. We hypothesize that aging-associated de-repression of retrotransposons promotes pro-
inflammatory changes of specific hematopoietic stem cell-supportive niche populations (marrow macrophages
and multipotent stromal cells) which drive clonal progression to myeloid neoplasms. To test this hypothesis,
using relevant models of clonal hematopoiesis we will examine whether 1) pre-leukemic mutations form clones
and progress to MDS more readily in the aged microenvironment by transplanting them into young versus aged
recipient mice; 2) SIRT6 overexpression in key microenvironmental populations slows the rate of
microenvironmental and hematopoietic aging, clonal expansion and progression to MDS; 3) repressing LINE1
retrotranspositions with inhibitors of reverse transcriptases (NRTIs) slows clonal expansion and provides a
mechanism to discover novel microenvironmental regulators of clonal hematopoiesis progression.

Public health relevance
Project Narrative This project is relevant to public health because it addresses a novel mechanism increasing progression of clonal hematopoiesis a common event in older individuals may lead to increased morbidity and risk of bone marrow failure and malignancy. If successful, it will provide a scientific basis for development of new strategies to prevent and/or treat these pathologies. It is also expected to advance the field of aging biology by elucidating how clonal hematopoiesis causes inflammation. This is highly relevant to the NIH mission of developing fundamental knowledge that will help to reduce the burdens of human disability.